Structure-based functional annotation of microbial genomes

Abstract
One of the most pressing challenges in modern biology is that of translating the massive amounts of
information on biological sequences that has been made available by recent advances in sequencing
technologies, into corresponding insights into the behavior of biological systems. Determining the functions and
physiological roles of proteins remains a major component of this challenge; for many species, especially
non-model microbes such as microbial pathogens, the fraction of the proteome consisting of poorly annotated
proteins may approach 50%, severely limiting our ability to even identify mechanisms of pathogenesis and
potential therapeutic targets. The massive number of poorly annotated proteins of potential biological
importance necessitates the ongoing development of efficient and reliable computational approaches for
functional annotation of proteins. Over the past few years, we have developed and applied several new
workflows for whole-proteome structure prediction and functional annotation of bacterial genomes, with
applications to laboratory strain E. coli K12 and to the minimal genome mycoplasma JCVI-syn3.0. Our
workflows are distinguished by the integration of structural information (including high-accuracy protein
structure prediction) in functional annotations, alongside classical methods such as sequence homology and
syntenty, and recent developments such as the inclusion of deep-learning based predictors; we find that
collectively, our workflows provide highly accurate functional annotations that are especially useful for ‘difficult’
protein targets without clear annotated homologs. We will now shift our focus to applying our tools to the
proteomes of bacterial pathogens, with an initial emphasis on uropathogenic E. coli. Specifically, we will
continue to develop our structure/function prediction capabilities to further improve accuracy and increase the
richness of information delivered (Aim 1), perform prediction-guided biochemical characterization of likely
virulence genes to assess predictive performance and identify potential pharmaceutical targets (Aim 2), obtain
experimental structures for proteins that are identified as difficult structural targets which likely represent novel
folds or unusual sequences for known folds (Aim 3), and test the physiological importance of likely
newly-identified virulence factors in an in vivo mouse model (Aim 4). The experimental data gathered under
Aims 2-4 will be continuously integrated with the ongoing methods development under Aim 1 to maximize the
performance and utility of the developed tools. The results of this project will include further improvements to
widely used and cited tools for rapid structure/function prediction, identification of specific virulence
determinants in uropathogenic E. coli and preliminary insights into how they may be targeted for
pharmaceutical intervention, and additional structural data of potential virulence factors that will aid in
structure-based drug design and improve coverage of existing structural template libraries to guide future
protein structure and function prediction.

Public health relevance
Project Narrative Recent technological leaps have allowed us to obtain the genome sequences of a huge range of organisms, but our ability to understand the functions of the proteins encoded in those genomes lags far behind. We will develop high-performance methods to predict protein structure and function from sequence, and apply these methods to identify the proteins used by uropathogenic E. coli (the bacteria causing urinary tract infections) to cause disease.